High-definition Endoscopic Ultrasound Navigation for Targeted Dual Neuromodulation Therapy

Project Summary/Abstract
31 million Americans suffer from Type 2 Diabetes Mellitus (T2DM) with numbers growing in the elderly and
children. An additional 84.1 million prediabetic Americans risk becoming diabetic. Current pharmaceutical
therapies have poor patient compliance and, along with bariatric surgical approaches, are expensive and have
negative side-effects. We have developed Targeted Dual Neuromodulation Therapy (TDN Therapy),
an innovative approach to blood glucose reduction. The closed loop TDN system (implantable pulse
generator (IPG), continuous blood glucose monitor (CGM) and bipolar nerve leads) senses elevated blood
glucose levels and reduces those levels by blocking conduction of the hepatic branch of the vagus nerve with
High Frequency Alternating Current (HFAC) while concurrently stimulating the celiac branch with Low
Frequency Alternating Current (LFAC). We hypothesize that esophageal and, or gastric High-definition
Endoscopic Ultrasound (EUS) will allow precise vagus branch identification and laparoscopic TDN nerve
lead placement with reduced off target physiological effects. In Preliminary studies, EUS imaging of nerves
within the celiac plexus and ganglion was successfully confirmed with a spyglass fiberoptic probe. These nerves
were then manipulated with biopsy forceps under EUS guidance and stimulated to modify gastric physiological
effects. This NIH-SBIR Phase I study will successfully demonstrate feasibility in swine as follows: Specific
Aim 1: Identify celiac and hepatic branches of the vagus nerve using endoscopic ultrasound and
or transillumination on endoscopy with feasibility confirmed by successful EUS guided imaging of the
vagus celiac and hepatic branches with further confirmation by fiberoptic probe. Aim 2: Use laparoscopy
with endoluminal EUS and endoscopy to place electrodes on the hepatic and celiac branching
points of the vagus nerve in a consistent manner with feasibility demonstrated by confirmation of
electrode placement by tracing the branches to the pancreas and liver during laparoscopy and necropsy. Aim
3: Minimize off target effects during stimulation of the hepatic and celiac branches with feasibility
demonstrated by determination of the lowest current amplitudes to minimize off target effects while staying in
a therapeutic current amplitude range. Evaluated off target effects will include non-GI effects of heart rate,
blood pressure, & the GI related off target effects of pyloric contraction & relaxation, lower esophageal
sphincter pressure, gastric & small intestinal contraction in the stomach. Liver effects will be assessed by
hepatic hormones, & portal & hepatic venous pressures. Pancreas effects will be evaluated by assaying insulin,
glucagon & GLP-1, amylase & lipase. Future Phase II efforts will incorporate EUS in TDN Therapy animal
implants for future FDA submissions.

Public health relevance
Project Narrative ReShape Lifescience’s Targeted Dual Neuromodulation Therapy (TDN Therapy) provides a disruptive therapy for Type 2 Diabetes Mellitus which eliminates negative side effects of current pharmaceutical therapies and bariatric surgeries. TDN Therapy involves an implantable neuromodulation device which detects high blood glucose levels and then blocks nerve impulse along the hepatic branch of the vagus nerve while concurrently stimulating the celiac branch of the vagus nerve to reduce blood glucose levels. High resolution esophageal endoscopic ultrasound will allow more precise identification and location of the vagus nerve branches to assure appropriate laparoscopic lead placement.